Single-molecule analysis of eukaryotic transcription activation

Project Summary/Abstract. The goal of this project is to better understand activation of transcription initiation
by eukaryotic RNA polymerase II (RNApII), a process that is often abnormal in cancer cells. Our system
combines Colocalization Single-Molecule Spectroscopy (CoSMoS, a TIRF microscopy technique for
simultaneously analyzing hundreds of single-molecule events) with Saccharomyces cerevisiae nuclear extracts
from strains with one or more transcription coactivators engineered for fluorescence labeling. Combining these
extracts with a transcription activator (that may be labeled with yet another color), we image binding of up to
three factors to DNA templates immobilized on the microscope slide. CoSMoS thus allows precise
measurements of interaction dynamics between promoter DNA, activators, co-activators, and the RNApII
transcription machinery. Specific Aim 1 extends our work on Mediator from the previous period. Having
established the temporal relationships between activator, RNApII, and the co-activator Mediator, we will
determine how the Tail and Kinase modules affect the process. We will further test our model that Mediator,
RNApII, and a subset of basal factors form a “pre-PIC” while bound to activators, poised for transfer of this
activation intermediate to the core promoter. Specific Aim 2 analyzes how activators “recruit” the coactivators
SAGA, Swi/Snf, and NuA4. These three factors act upon nucleosomes, so our experiments compare naked
versus chromatinized templates, immobilized side-by-side on the same microscope slide. Experiments labeling
different combinations of coactivators will reveal if their binding is independent, sequential, simultaneous, or
mutually exclusive. Finally, Specific Aim 3 looks at how the characteristics of the activators themselves
influence coactivator interactions. As a model system, we compare different activation domains (VP16, Gcn4,
Rap1, et al.) fused to the same Gal4 DNA binding domain. We are also studying the natural yeast activator
Gcn4. Using matched promoters having single versus multiple Gal4 binding sites, we are uncovering direct
evidence for transcription synergy and mechanisms of cooperativity. Interestingly, there are measurable
differences in dynamics produced by different activation domains and different coactivators. These
experiments will reveal whether transcriptional synergy reflects increased binding frequencies, durations,
and/or co-occupancy of coactivators and Mediator/RNApII. Together, these single molecule experiments will
reveal fundamental information about transcription activation that has been impossible to glean from ensemble
biochemical or genomic techniques. The yeast system is well established as an excellent model system for all
eukaryotes, and findings here will provide deeper understanding of the mammalian homologs that are very
frequently mutated in cancer.

Public health relevance
Project Narrative. Improper gene expression is a hallmark of cancer, and many oncogenes encode mutated transcription activators or co-activators. The goal of this project is to better understand how these transcription factors function by applying new single molecule technology. This understanding will be essential for designing treatments and drugs to restore normal gene expression in diseased cells.